Tracking and Evaluation Core

The Tracking and Evaluation (Eval) Core aims to support the leadership and programs of the Oklahoma
Shared Clinical and Translational Resources (OSCTR) by assessing progress toward stated goals and
improving the effectiveness and efficiency of OSCTR core strategies. The overall commitment to evaluation is
demonstrated by the integration of tracking and monitoring activities throughout each OSCTR core and its
specific aims. The Eval Core continues to build and refine logic models for each core with measurable
outcomes that have been invaluable in both strategic planning and evaluation for the OSCTR. Infrastructure
was developed to facilitate activity tracking and evaluation that provides support and services to the OSCTR,
as well as other large institutional grants. The Eval Core has helped to assess large programs of the OSCTR
by completing in-depth evaluation studies of major OSCTR activities, including the Pilot Projects Program and
Translating Practice into Research, allowing leadership to identify key refinements to improve programs and
identify underperforming processes or gaps in knowledge. Our approach to evaluation will continue to focus
on process and outcome measures, in which OSCTR leaders, investigators, and other stakeholders are active
in prioritizing, framing, capturing, and using, for overall program improvement. The Eval Core will continue to
evaluate the overall operational functions and outcomes of the OSCTR cores by assessing short- and long-
term goals, monitoring program implementation, and tracking resource utilization. The Core will continue to
find innovative means to address the efficiency, quality, and impact of OSCTR strategies through enhanced
tracking mechanisms involving bibliometric analyses, return on investment calculations, and social network
analyses. This renewal offers a new opportunity for the Eval Core to move beyond process metrics and
measurements and work closely with the Administrative Core to expand assistance to all OSCTR cores and
support junior investigators to better share their successes and disseminate efforts that promote peer learning.
This will help accomplish a major objective of the OSCTR to establish the next generation of scientific leaders
at our partners by continuing and optimizing the professional development of promising young investigators.
Finally, the OSCTR Eval Core will continue to work with the Tracking and Evaluation Cores of the other IDeA-
CTR awardees to share best practices and lessons learned through the evaluation activities of these centers
and utilize those findings to improve the overall processes and outcomes of the OSCTR.